Washington University/Siteman Cancer Center Lead Academic Site

Project Summary
The fundamental goal of the proposed Washington University/Siteman Cancer Center
(WU/SCC) NCTN Lead Academic Participating Site UG1 is to 1) foster scientific leadership and
mentorship in the NCTN, 2) participate in the development of NCTN therapeutic, correlative,
and cancer control trials, and 3) maintain strong accrual to clinical trials across multiple disease
sites, including those that are molecularly driven and those for rare cancers. WU/SCC
investigators have a long history of enthusiastic participation in the former cooperative group
program and continue to play key roles in the current NCTN program, specifically the Alliance
for Clinical Trials in Oncology, ECOG-ACRIN Cancer Research Group, and NRG Oncology.
WU/SCC will have 5 UG1 co-Principal Investigators comprising the senior leadership team
including Nancy L. Bartlett, MD (Professor, Medical Oncology), Benjamin Kozower, MD, MPH
(Professor, Thoracic Oncology), Premal Thaker, MD (Professor, Gynecologic Oncology),
Clifford Robinson, MD (Associate Professor, Radiation Oncology) and Barry A. Siegel, MD
(Professor, Radiology). The WU/SCC senior leadership team is composed of three legacy
members with extensive cooperative group and NCTN experience (Bartlett, Mutch and Siegel)
and two new members (Robinson and Kozower) with experience in NCTN trial development.
The entire leadership team is committed to providing guidance for an institution-wide NCTN
UG1. WU/SCC has consistently demonstrated robust accrual to NCTN trials, accruing 1217
patients between March 2019 and August 2024. The strength of the WU/SCC genomics,
proteogenomics, and molecular imaging programs in combination with the large institutional
biorepositories position us to make significant and novel contributions to the scientific mission of the
NCTN. WU/SCC investigators remain highly invested in NCTN translational and clinical research in
AML, lymphoma, lung cancer, breast cancer, sarcoma, uterine cancer, molecular imaging, and
radiation oncology. In addition, our large referral base and the substantial increase in new cancer
cases seen at our center in the last 5 years will enhance our ability to accrue patients to nearly all
disease site protocols, including rare tumors. This institution-wide UG1 will facilitate enhanced
communication and collaboration among disease-site, translational, and modality specialists and
improve our potential for contributions to the NCTN operation.

Public health relevance
Project Narrative SCC is the only NCI-designated Comprehensive Cancer Center in Missouri and Southern Illinois and it is the leading oncology treatment facility within the St. Louis metropolitan area. Participation in the NCTN allows WU/SCC physicians to offer a broad range of clinical trials to patients with all types and stages of cancer and also provides an opportunity for investigators to confirm preliminary institutional findings regarding new cancer treatments, diagnostic tools, and prognostic markers in large numbers of patients.